Determining the Involvement of PERK in TMAO Induced Atherosclerosis

ABSTRACT:
The World Health Organization reports cardiovascular disease (CVD) as the global leading cause of death.
Our long-term goal is to improve public health by advancing clinical therapies and management of CVD.
Trimethylamine N-oxide (TMAO) has emerged as a dietary derived metabolite highly predictive of atherosclerosis
and CVD mortality. It is robustly elevated in humans with CVD across multiple independent studies, and its
dietary supplementation causes atherosclerosis in animal models. But efforts to leverage the TMAO pathway
therapeutically are met with skepticism, as a clear mechanism of TMAO action continues to be elusive.
Therefore, defining the mechanism of TMAO-induced atherosclerosis is of fundamental importance to produce
meaningful change in treatment options for those dying of CVD. Recently, our lab reported the first and only
known receptor for TMAO; TMAO specifically binds and activates the stress signaling kinase PKR-like
Endoplasmic Reticulum Kinase (PERK). However, two central questions are still unaddressed: 1) how does
TMAO-activation of PERK drive disease, and 2) is PERK activity required for TMAO to cause atherosclerosis?
This proposal presents a research strategy to answer the above questions. We report preliminary data that acute
TMAO causes PERK phosphorylation (pPERK) in mouse aorta, and that chronic TMAO feeding increases aortic
inflammation in a PERK dependent manner. We also show use of a PERK inhibitor prevents TMAO-induced
increases of CVD risk factors, blood glucose and plasma cholesterol. Further, we confirm that TMAO activates
pPERK, but also that it induces a unique conformational state distinct from classically described PERK activation
by unfolded proteins. Thus, our central hypothesis is that TMAO drives atherosclerosis via a unique
activation of the PERK axis. In Aim 1, we propose to define TMAO’s effects on the PERK signaling complex
in the vasculature. In Aim 2, we will test the requirement of PERK in TMAO’s ability to cause atherosclerosis in
ApoE-/- mice. The experiments described will identify a long-sought mechanism of how TMAO causes
atherosclerosis, and they will investigate how activation of the stress response protein, PERK, induces cellular
dysfunction. The proposed training plan covers training in molecular and physiologic tools to assess metabolic
contributions to CVD, presentation, communication, and publication opportunities, and an overall roadmap for
growing into a productive and collaborative independent investigator. Additionally, the institutional environment
at both the Harvard T.H. Chan School of Public Health and Boston Children’s Hospital ensures robust access to
abundant resources and equipment, core facilities, and brilliant minds that will continually support the growing
needs of the project. We believe the enclosed aims will interrogate the role of PERK in mediating the well-
described effect of TMAO-induced CVD, and they will open a flood gate of therapeutic options already lying-in
wait to prevent premature cardiovascular deaths.

Public health relevance
PROJECT NARRATIVE: Trimethylamine N-oxide (TMAO) is a common dietary derived metabolite that has emerged as a central driver of cardiovascular disease. But efforts to leverage this pathway therapeutically have been impeded by a lack of a clear mechanistic understanding of TMAO action. Therefore, we propose to define how TMAO causes atherosclerosis by defining TMAO’s direct effects on its only known receptor and elucidating the TMAO atherogenic stress response.